BCCMA: Cardiovascular Remodeling following Arteriovenous Fistula Creation: Aging Contributes to Adverse Arteriovenous Fistula Remodeling

Arteriovenous fistulas (AVFs) are the preferred vascular access for hemodialysis patients with end stage kidney
disease (ESKD). A large proportion of AVFs (30-60%) created in the United States fail to successfully mature
(i.e., lack sufficiently large lumen and blood flow) and require assisted maturation for dialysis use. The high
failure rates after AVF creation reflect our poor understanding of the mechanisms leading to AVF maturation
failure, and the lack of therapies to prevent or treat this problem represents an unmet clinical need. This BCCMA,
entitled “Cardiovascular Remodeling following Arteriovenous Fistula Creation”, is an integrated and
synergistic proposal assembling a group of Veteran Affairs investigators focused on improving AVF maturation
failure for Veteran hemodialysis patients. The Overall Research Strategy is to elucidate mechanisms of AVF
maturation failure in order to develop novel therapies to mitigate this unmet clinical need. The overall rationale
for this BCCMA is that fibrotic venous remodeling promotes intimal hyperplasia development to restrict lumen
area for blood flow, and mitigating these biological problems could improve successful AVF maturation. The
specific aims of this BCCMA will define mechanisms by which senescence and aging in endothelial cells (EC)
(Project 1), Type VIII collagen in smooth muscle cells (SMC) (Project 2), and autophagy in EC (Project 3)
determine venous remodeling after AVF creation. The overarching hypothesis of this BCCMA project is that the
biology of AVF maturation is influenced by mechanisms regulating venous fibrotic remodeling. In Project 1,
entitled “Aging Contributes to Adverse Arteriovenous Fistula Remodeling”, we aim to advance our
understanding of senescence- and aging-related AVF maturation failure and develop treatments to enhance AVF
maturation. Our central hypothesis is that disturbed flow decreases sirtuin 1 (SIRT1) and the shelterin protein
telomeric repeat binding factor 2 (TRF2) to induce senescence-associated secretory phenotype (SASP) in EC,
which results in profibrotic signaling to cause fibrosis and AVF maturation failure. We also hypothesize that
chronological aging enhances EC SASP transformation under disturbed flow. We will test our hypotheses with
three specific aims. Aim I: Demonstrate the roles of endothelial SIRT1 and TRF2 in disturbed flow-induced
SASP and profibrotic signaling (in vitro aim). Aim II: Demonstrate the causality of endothelial SIRT1 and TRF2
in SASP, venous fibrosis, and AVF remodeling in mice (in vivo aim). Aim III: Demonstrate the associations of
endothelial SIRT1-TRF2-SASP levels with venous fibrosis and AVF maturation in hemodialysis patients (human
aim). The knowledge gained by completing the proposed aims will help to identify novel pharmaceutical targets
for the prevention/treatment of AVF maturation failure.

Public health relevance
The arteriovenous fistula (AVF) is the preferred vascular access for hemodialysis patients in the United States. However, despite all technological and surgical advances, AVF maturation failure remains the primary source of hospitalization and complication in the hemodialysis population. The annual costs of treating vascular access dysfunction total over two billion U.S. dollars, because of the high proportion of non-maturing AVFs, resulting in numerous interventions to promote maturation and complications from prolonged hemodialysis catheter use. Project 1 investigates mechanisms underlying aging- and senescence-related AVF maturation failure. The proposed research is relevant to Veterans’ health because over 80% of veterans with end-stage kidney disease are on hemodialysis. The proposed research will advance our understanding of AVF remodeling processes and lead to the development of novel therapies to treat this important clinical problem, reduce medical complications, and ultimately save lives of veterans requiring hemodialysis therapy.